Education/Training and Outreach Activities

PROJECT SUMMARY (See instructions): As an integral part of the CCNE, we propose to create a pre-doctoral and post-doctoral training program in cancer nanomedicine that will: (1) bridge the gap in language and skills between the physical sciences/engineering and cancer biology/oncology communities, (2) contribute to the creation of new knowledge and new technologies, and (3) train a new generation of multidisciplinary scientists and engineers in cancer nanomedicine. SPECIFIC AIMS Aim 1 (Education/Training). To recruit pre-doctoral students and post-doctoral fellows with backgrounds in the biological sciences, physical sdences, or engineering. Special efforts will be conducted to recruit, retain, and mentor trainees from under-represented groups. Aim 2 (Education/Training). To train a new generation of mulddisciplinary scientists, engineers, and clinicians in cancer nanomedicine. Aim 3 (Education/Training). To provide students and fellows the opportunity to conduct research in cancer nanomedicine. Each trainee will be co-mentored by at least one faculty in the physical sciences/engineering and at least one faculty in cancer biology/oncology. Aim 4 (Education/Training and Outreach). To provide CCNE researchers the opportunity to visit other CCNEs by establishing an exchange program. Aim 5 (Outreach). Establish a comprehensive set of outreach activities to disseminate the new knowledge and new technologies created in the proposed CCNE to the relevant scientific communities and constituencies.